Harnessing Data Science to Promote Equity in Injury and Surgery for Africa

PROJECT SUMMARY/ABSTRACT
Trauma and other surgically treated conditions are a crippling, unaddressed burden of disease that
disproportionately impacts sub-Saharan Africa (SSA) globally. The Data Science Center for the Study of
Surgery, Injury, and Equity in Africa (D-SINE-Africa) is a strategic partnership between the University of Buea
(Buea), the University of California (Los Angeles (UCLA) and Berkeley), the Cameroonian Ministry of Public
Health, the African Institute for Mathematical Sciences in Cameroon, and the University of Cape Town in South
Africa. D-SINE Africa will address the intersection of health disparities with the risk factors and outcomes
associated with injury and surgical disease in SSA. Although more abundant than ever, data is still a limited
resource in low- and middle-income countries. Our approach views “big data” available in SSA as an
opportunity to develop sustainable data-constrained approaches appropriate for resource-constrained settings.
Thus, data science will be harnessed to address our Hub's two main goals which are;1) to decrease the
burden of injuries and surgical diseases through improved surveillance, prevention, and treatment; and 2) to
improve access to quality surgical care in Cameroon and other SSA countries. These goals will be achieved
through three specific aims: 1) Research 2) Networking and 3) Capacity Building. These aims implemented
through three cores (Administrative, Data Management and Analysis, and Capacity Building Cores) and two
Research Projects that will be conducted in Cameroon, South Africa, and Uganda. Research Project 1 - Health
Equity Surveillance addresses the urgent gap in rapid socioeconomic (SES) estimation necessary to track
health equity in acute care settings by applying a clustering algorithm to existing publicly available
Demographic and Health Surveys data sets for SSA. Research Project 2 – Trauma Follow Up Prediction aims
to improve trauma outcomes by using machine learning to optimize a mobile phone-based screening survey
that will identify which trauma patients would benefit from further care after they are discharged from the
hospital, again using a data reduction “big data to small data” approach in line with the Hub's commitment to
sustainable data use practices. These projects utilize common data sources (Cameroon Trauma Registry),
have harmonizing themes (injury, equity, and data reduction), and will yield findings that can be used together
(e.g., identification of SES groups vulnerable to poor follow up care). The Hub has innovatively built community
engagement vehicles into the Internal Advisory Board to promote a multi-faceted approach to building trust
with research participants and end-users. D-SINE Africa efforts will drive innovation and impact in data
science, injury, and equity research to improve access to surgical disease prevention and care, including those
whose SES conspires to increase their vulnerability to injury and surgical conditions while reducing consistent
surgical care access. D-SINE Africa's strategic partners joint infrastructure are available for use by its
members and DSI-Africa consortium at large.

Public health relevance
PROJECT NARRATIVE Injuries and other surgically treated diseases comprise a significant burden of disease in Cameroon and other sub-Saharan African (SSA) countries with deep inequities that are particularly unmasked in acute care settings. D-SINE Africa Hub will focus on the intersection between injury and equity, leveraging data science to decrease the impact of trauma, surgical disease, and disparities on the population of Cameroon and SSA by promoting collaborative research, networking, and capacity building with an emphasis on equity.